Identifying a role for the lateral habenula in typical and perturbed social behavior development

Project Summary
For many species, access to resources requires a highly flexible system of social behavior that is
sensitive to environmental demands. Indeed, inflexible social behavior can be highly maladaptive, particularly
during developmental transitions when social demands are in constant flux. Yet, the neural substrates supporting
flexible social behavior during development have been underexplored. Due to technical limitations, it has been
challenging to identify the circuits responsible for social cue processing in the infant brain and how these go awry
in atypical development. Using recent advances in infant rodent neural circuit dissection, this proposal aims to
address this gap in our understanding. We focus on the lateral habenula (LHb) and its connections with the
medial prefrontal cortex (mPFC) because this circuit is critical for behavioral flexibility in adults. We propose a
central hypothesis that functional inclusion of the LHb in the social behavior circuit transitions a system favoring
social approach within the nest to one favoring a balance of approach and avoidance as infants gain
independence and enter the complex social world. This transition is postulated to occur via enhanced modulation
by the mPFC at weaning age. The goal of this proposal is to test this hypothesis using advanced circuit dissection
tools in the pre-weaning (PN14) and post-weaning (PN23) rat pup across three Aims. First, we will ask how LHb
engagement controls transitions in social behavior during typical development. To address this question, we will
use complementary ex vivo (metabolic imaging, Aim 1a) and in vivo approaches (fiber photometry, Aim 1b) to
measure LHb function during social behavior in PN14 and PN23 animals. Then we will assess causation by
optogenetically controlling LHb activity during social behavior at these two ages (Aim 1c). As the LHb is
distinctive for its role as a relay center between the forebrain and monoaminergic centers in guiding behavior,
Aim 2 is designed to assess how LHb circuits control developmental transitions in social behavior. In this Aim,
we will assess network-level changes of 2-DG uptake during social behavior in extended LHb circuits as a
function of development (PN14 versus PN23) (Aim 2a). Next, we will measure (photometry) and manipulate
(optogenetics) identified projections at both ages to determine their role in developmental transitions in social
approach (Aims 2b-c). Finally, we will use a multiplexed chemogenetic approach to simultaneously control LHb
network populations to determine their respective roles in behavioral transitions (Aim 2d). The goal of Aim 3 is
to leverage the advanced circuit mapping techniques described in Aims 1 & 2 to test the hypothesis that
caregiving adversity accelerates LHb inclusion in social behavior networks to prematurely inhibit social approach.
By perturbing this system while it is still being built, the proposed experiments will identify how early experience
sculpts developing LHb circuit architecture to generate maladaptive social behavior. Together, these studies will
provide a technical and conceptual advance in our understanding of the developing social brain and the impact
of perturbing this delicate system.

Public health relevance
Project Narrative Social behavior deficits are common features of myriad psychiatric illnesses known to have roots in early development, including autism, schizophrenia and anxiety. Yet, there is little understanding of the ontogeny of social behavior in typically-developing individuals. The proposed studies are aimed towards dissecting the neural circuitry supporting flexible social behavior in typical and perturbed development.